Integrated Care for Chronic Pain and Opioid Use Disorder: The IMPOWR Research Center at Montefiore/Einstein (IMPOWR-ME)

ABSTRACT
Chronic pain and opioid use disorder (OUD) are leading causes of morbidity and mortality in the United States.
Despite being commonly comorbid, there is a striking lack of integrated, non-pharmacologic treatments
accessible to people in need. Submitted in response to the HEAL Initiative: Integrative Management of Chronic
Pain and OUD for Whole Recovery (IMPOWR) RFA-DA-21-030, the overall goal of this proposal is to support
the IMPOWR Research Center at Montefiore/Einstein (“IMPOWR-ME”). IMPOWR-ME is a synergistic
multidisciplinary research center that leverages exceptional research infrastructure in chronic pain and OUD
and existing relationships with people living with chronic pain and OUD and other stakeholders. The aims of
IMPOWR-ME are to: 1) create a robust and sustainable research infrastructure to rigorously test and
disseminate integrated and cost-effective evidence-based practices for people with chronic pain and OUD; 2)
partner with people with lived experience with chronic pain, OUD, or both, and other stakeholders in all stages
of the research; and 3) provide opportunities for multidisciplinary early stage investigators to become
independent researchers focusing on chronic pain and OUD. Two innovative hybrid type 1 effectiveness-
implementation trials are: 1) a three-arm trial of yoga and physical therapy onsite at methadone opioid
treatment programs, and 2) a three-arm trial to test Acceptance and Commitment Therapy and a care
management smartphone app for individuals in primary-care based buprenorphine treatment. Participants in
both projects have both chronic pain and OUD or opioid misuse, and specific aims for each project examine
chronic pain, OUD, implementation, and cost-effectiveness outcomes. The projects have high potential for
dissemination and sustainability and aim to promote physical activity and physical and mental health.

Public health relevance
PROJECT NARRATIVE The IMPOWR Research Center at Montefiore-Einstein (IMPOWR-ME) is a multidisciplinary research program to test integrated, non-pharmacologic approaches that address both chronic pain and opioid use disorder. IMPOWR-ME will generate critical knowledge about the effectiveness, implementation, and cost- effectiveness of providing onsite yoga classes or physical therapy in opioid treatment programs and providing Acceptance and Commitment Therapy and/or a care management smartphone app for individuals in primary care-based buprenorphine treatment. People with lived experience with chronic pain and/or opioid use disorder and other stakeholders are engaged in all stages of the research. IMPOWR-ME is a hub for research focused on aiding recovery through promoting physical and mental health for people with chronic pain and opioid use disorder.